MANUFACTURING CGMP GRADE HYDROXYCOBALAMINE

The scope of this contract is for generating a 2 Kg GMP batch of Hydroxocobalamin (OHCbl). The
contractor shall provide the Certificate of Analysis (COA), a Quality Overall Summary (Module 2.3.S) or a
DMF file number, and material safety data sheet.